Automated CRISPR Enabled DNA Synthesis (CEDS)

Abstract
We propose to develop a novel method for low cost DNA synthesis: CEDS (Crispr enabled DNA
synthesis). The CEDS approach overcomes many of these challenges and enables template
independent, exponential single- stranded DNA synthesis. We have preliminary results
supporting key biochemical steps in the CEDS workflow, including both ssDNA ligation and Cpf1
mediated ssDNA cleavage at the target strand. Our longer term goal is to develop the technology
to support the overnight synthesis of a 10 kbp plasmid at a cost of <$10.00 which would be
$0.001/bp in synthesis cost (not including the costs of sequence verification).

Public health relevance
Narrative This program is focused on optimization and automation of a novel DNA synthesis technology CRIAPR-Enabled DNA synthesis (CEDS); and more specifically, enzymatic cycles which enable exponential growth in linear ssDNA. Work will be focused on optimization of these cycles, as well as development of optimal algorithms and workflows.